Early Childhood Neurodevelopmental, Economic and Nutritional Outcomes among Former Very Low Birth Weight Infants from the Reducing Disparity in Mother's Own Milk (ReDiMOM) Trial

Project Summary
Although most very preterm (VP; <32 weeks gestation) infants survive to discharge from the neonatal intensive
care unit (NICU), they remain at heightened risk for impaired neurodevelopment (ND), obesity and
cardiometabolic conditions, burdening families and translating to high healthcare costs over the lifespan. One
strategy to reduce these risks is to feed mother’s own milk (MOM) during the NICU hospitalization, because
MOM is associated with a dose-dependent enhancement in early brain development, better ND outcomes, and
a reduced risk of obesity and its complications. Observational studies have documented health and economic
benefits associated with MOM, but all of these studies have been limited by the inability to ethically randomize
VP infants to receive different doses of MOM. Although exclusive MOM feedings through the first 6 months of
life are recommended for all infants, mothers of VP infants face numerous barriers in providing MOM. Almost
50% of mothers discontinue MOM provision before NICU discharge, well before their infants reach 6 months of
age. Our ongoing NIH-funded randomized controlled trial, “Reducing disparity in the receipt of mother’s own
milk in very low birthweight infants: An economic intervention” (ReDiMOM, R01MD013969) was designed to
test the effectiveness of an economic intervention that covers the maternal costs of providing MOM in the
NICU. ReDiMOM provides an economic bundle to intervention group mothers: free hospital grade electric
breast pump rental, free pickup of pumped MOM from the home, and payment for each day spent pumping to
offset maternal opportunity costs. Both intervention and control group mothers receive standard NICU-specific
lactation care. This ethical randomization of an intervention to achieve higher NICU MOM doses in the
intervention group provides the first opportunity to obtain experimental evidence of MOM’s impact on health
and economic outcomes in early childhood. Leveraging the randomized design of ReDiMOM, the overall aim of
this study is to assess ND (cognitive, language and motor index scores), adiposity, and duration of MOM
feedings, total cost of care and cost-effectiveness through 20 months’ corrected age, without residual
confounding concerns. Additionally, this study will assess the relationship between total duration of MOM
feeding (in NICU and post discharge) and early childhood outcomes using a robust cohort design. This study
provides an unparalleled opportunity to obtain experimental evidence of the effect of MOM feedings on early
childhood ND and adiposity in VP infants without unmeasured confounding. It will provide the highest quality of
evidence for decision makers and essential economic data needed to compare the two NICU lactation
strategies employed in ReDiMOM. The impact will be on prioritizing investment in effective strategies that
support MOM for VP infants and reduce inequities in the receipt of MOM, ultimately leading to improved
outcomes for all VP infants.

Public health relevance
Project Narrative This study will evaluate the long-term effectiveness of an economic intervention designed to facilitate maternal adherence to pumping and providing mother’s own milk to very preterm infants by covering the costs that serve as barriers to sustained mother’s own milk feedings during the neonatal intensive care unit hospitalization. Additionally, the study will assess the relationship between the total duration mother’s own milk is received during the first year of life and early childhood outcomes in this population of vulnerable infants.